Adapting Single Sessions Interventions for Type 1 Diabetes (ASSISTED): Integrated Pediatric Care to Reduce Depression and HbA1c

PROJECT SUMMARY/ABSTRACT
Type 1 diabetes (T1D) is a common pediatric chronic medical condition that involves a complex daily regimen.
Most children and adolescents with T1D do not meet glycemic control recommendations, suggesting that many
likely struggle to manage T1D effectively. Behavioral interventions exist to help youth with T1D engage with their
treatment regimen and achieve lower glycemic levels. However, in diabetes clinics, it is challenging to implement
these interventions because they are costly to deliver, often involve multiple sessions spanning weeks or months,
and require access to mental health providers. The recently emphasized practice of depression screening in
pediatric diabetes clinics has increased the number of mental health referrals, as 20-30% of youth with T1D
endorse elevated depressive symptoms. Yet, most pediatric diabetes clinics are understaffed with mental health
providers, and only <25% of youth referred for outpatient treatment follow through with an appointment. Targeted
single-session interventions (SSIs) may alleviate barriers to accessing traditional outpatient therapy and reduce
depressive symptoms in youth with T1D, but an SSI that incorporates evidence-based strategies to treat
depressive symptoms and lower HbA1C for youth with T1D does not yet exist. The proposed K23 career
development award aims to address these gaps in research and clinical care by adapting and pilot testing a
T1D-specific depression SSI integrated into pediatric T1D medical care. The first goal is to create a T1D-specific
depression SSI treatment manual by eliciting feedback from a small group of adolescents. The second goal is to
examine the feasibility, acceptability, and initial efficacy of an integrated T1D-specific depression SSI approach
in a randomized pilot trial to reduce depressive symptoms and lower glycemic levels in youth with T1D. The third
goal is to understand the barriers and facilitators of implementing the SSI approach in diabetes clinics for further
refinement in follow-up testing. Piloting an integrated SSI approach could lead to improvements in the acute and
long-term psychological and physical health of youth with T1D and increase the accessibility, scalability, and
cost-effectiveness of psychological treatment within pediatric T1D care. Moreover, this research plan supports
the candidates’ career development goals of gaining advanced training in clinical trial research design and
methods, becoming an expert in feasible and flexible intervention designs (e.g., SSIs), enhancing knowledge of
integrated healthcare in pediatric diabetes, and developing interventions that minimize barriers to care. Through
a combination of formal didactics and direct mentored training experiences with her mentoring team, Dr. Monzon
will gain the necessary knowledge and skills to implement the proposed research project and transition toward
an independent research career. Further, the findings from the proposed project will inform an R01 application
to conduct a larger, multisite randomized trial that has sufficient power to examine the efficacy of the T1D-specific
depression SSI.

Public health relevance
PROJECT NARRATIVE Most children and adolescents with type 1 diabetes (T1D) do not meet glycemic control recommendations, which places them at risk for developing acute and long-term complications, and up to a third of youth with T1D report elevated depressive symptoms. The proposed research aligns with NIDDK’s mission to improve the health and quality of life of individuals living with diabetes by using a novel single-session intervention (SSI) approach to improve depressive symptoms and glycemic levels in youth with T1D. The proposed research and the career development plan developed by the candidate and mentoring team will result in an innovative T1D-specific depression SSI with the potential to significantly improve health and access to mental health care for adolescents with T1D who report elevated depressive symptoms.